Viral miRNA Essentiality in Primary Effusion Lymphoma

PROJECT SUMMARY
Kaposi's Sarcoma-Associated Herpesvirus (KSHV) is the etiological agent of several AIDS/HIV-associated
human neoplasms, including the B cell malignancy primary effusion lymphoma (PEL). During PEL
pathogenesis, KSHV remains predominantly latent, expressing few proteins and approximately 25 mature
microRNAs (miRNAs). Despite their identification nearly two decades ago, the roles of the KSHV miRNAs in
PEL remain poorly understood, partially due to challenges in achieving lasting miRNA loss-of-function.
Specifically, the high copy number of KSHV genomes in PEL precludes CRISPR-based KSHV genome editing
and transfectable antisense inhibitors only achieve transient inhibition. My goal is therefore to leverage novel
insights into the endogenous miRNA turnover mechanism to define the essentiality of KSHV miRNAs in PEL
cell lines. In my preliminary work, I have already improved upon lentivirally-deliverable miRNA inhibitors to
achieve stable miRNA inhibition in cultured PEL cells. My preliminary data suggests that at least one KSHV
miRNA, miR-K11, a highly expressed KSHV mimic of the oncogenic human miRNA miR-155, is essential for
PEL cell viability. My proposal seeks to broaden our understanding of KSHV-encoded miRNAs. My overall
hypothesis is that individual KSHV miRNAs promote the survival or proliferation of PEL cells. I further
hypothesize that miR-K11 plays a central role in PEL oncogenesis, by repressing specific uncharacterized
target mRNAs. To investigate these hypotheses, I propose two Specific Aims. In Specific Aim 1, I will design,
validate, and employ lentiviral miRNA inhibitors to determine the importance of each KSHV miRNA for the
viability or proliferation of a set of PEL cell lines. For miRNAs with significant essentiality, I will assess their
effects on the cellular and viral transcriptomes, KSHV lytic reactivation, apoptosis, and cell cycle progression.
In Specific Aim 2, I propose to define the essential role of miR-K11 in PEL. I will first extend my finding that
miR-K11 is required for the viability of PEL cells to an extended set of PEL cell lines. I will then use genome-
wide and custom CRISPR rescue screens to identify which miR-K11 targets underlie miR-K11 essentiality. I will
mine hits from these screens, new RNA-seq experiments, and published KSHV miRNA targetome data sets, to
prioritize and validate functionally essential targets of miR-K11. Collectively, my research plan will define the
importance of KSHV encoded miRNAs and identify the functionally essential targets of miR-K11 in PEL. Since
miR-K11 mimics a cellular miRNA that contributes to human lymphomas, my results will also be broadly
relevant to mechanisms of lymphomagenesis, potentially paving the way for new therapeutic strategies. My
research plan will finally allow me to gain invaluable skills in molecular biology, bioinformatics, mentoring, and
written and oral presentations, helping me reach my goal of running an independent research laboratory at an
academic institution.

Public health relevance
PROJECT NARRATIVE Kaposi’s Sarcoma-Associated Herpesvirus (KSHV) is a primary cause of several AIDS-associated cancers. This research aims to determine the roles of KSHV-encoded microRNAs (miRNAs), which have largely remained unknown. Results will not only deepen our understanding of how KSHV causes cancer but also provide broader insights into cancer biology, offering potential avenues for improved therapeutic strategies across various malignancies.